DIAZOXIDE EFFECT ON GLUCOSE KINETICS

To quantify the effect of diazoxide on glucose kinetics and insulin in healthy adults, in order to better understand the drug's actions when it is used therapeutically to treat infants with hypoglycemia due to an inborn metabolic error.